Project 1 - Targeting PIKfyve-driven lipid homeostasis as a metabolic vulnerability in neuroendocrine prostate cancer

Neuroendocrine prostate cancer (NEPC) is an aggressive form of advanced prostate cancer (PCa) with few
treatment options other than systemic chemotherapies, for which patients invariably develop resistance.
Targeted therapies are, thus, urgently needed for this lethal disease. Although NEPC can arise de novo, most
cases result from an adenocarcinoma to neuroendocrine transdifferentiation process that occurs in tumors of
castration-resistant PCa (CRPC) patients receiving standard of care therapies targeting the androgen receptor
(AR). The tumor microenvironment of NEPC is often hypoxic and nutrient-depleted, leading to enhanced
dependence on autophagy and lysosome-dependent nutrient survival pathways within cancer cells. Blocking
autophagy with genetic methods suppresses tumor growth and increases survival in preclinical models. Here,
we have identified the lipid kinase PIKfyve as a key player mediating autophagy and lysosomal adaptation
processes in NEPC. Interestingly, although AR-positive CRPC is sensitive to PIKfyve inhibitors in vitro, PIKfyve
inhibitor treatment results in cytotoxicity in NEPC cells and enhanced tumor growth inhibition and regression.
Our preliminary data also suggest that PIKfyve inhibition results in increased de novo lipid synthesis and that
combined targeting of the MAPK pathway and PIKfyve may be a synthetic lethal strategy for NEPC. Here, we
will develop potent, selective PIKfyve degraders and employ them to validate PIKfyve as a viable therapeutic
target for NEPC. Pathways leading to enhanced activity of PIKfyve inhibition (e.g., MEK inhibition) in NEPC will
also be delineated. The following Specific Aims are proposed: Aim 1: Employ novel proteolysis-targeting
chimera (PROTAC) degraders to define the mechanism by which PIKfyve loss preferentially impacts
NEPC. PIKfyve inhibitors (apilimod, ESK981) and PROTAC degraders will be used in this aim to confirm the
molecular mechanisms through which PIKfyve mediates preferential effects in NEPC, focusing on key nutrient
survival pathways, endoplasmic reticulum stress/unfolded protein response, and lipid homeostasis. Aim 2:
Define synthetic lethality relationships with PIKfyve antagonism in NEPC. Our preliminary data suggests
that MAPK pathway inhibition antagonizes de novo lipid synthesis. Here, we will determine whether MEK
inhibitors sensitize NEPC cells to PIKfyve degraders in vitro and in vivo. Aim 3: Determine whether PIKfyve
degradation combined with standard of care therapies for NEPC enhances outcomes in preclinical
models. Cell line and patient-derived organoid and xenograft models will be used to test the efficacy and safety
of PIKfyve degraders alone and in combination with cisplatin for NEPC. Aim 4: Establish an investigator-
initiated phase II trial evaluating a clinical PIKfyve inhibitor (ESK981) in NEPC. Biomarkers of response will
be identified through correlative studies. This project will define PIKfyve as a new therapeutic target for NEPC,
thereby adding to the limited treatment options for these patients. As an alternate strategy, orally bioavailable
PIKfyve degraders will be transitioned into the clinic.

Public health relevance
The lipid kinase PIKfyve is an important regulator of cellular autophagy and lysosomal adaptation processes, two pathways that are elevated in hypoxic and nutrient-depleted settings such as those that occur in lethal, aggressive neuroendocrine prostate cancer (NEPC). In this project, we will validate PIKfyve as a critical regulator of NEPC growth and survival as well as assess the efficacy of PIKfyve inhibition and degradation as a strategy to enhance response to standard of care treatments in NEPC. An early phase clinical trial of a PIKfyve inhibitor will determine the efficacy of monotherapy and identify biomarkers of response.